Cartilage Regeneration with Tunable Inflammation Resistance

Abstract: Femoroacetabular impingement or FAI is a commonly diagnosed condition affecting a younger
patient population than the general osteoarthritis (OA) population. Untreated, FAI invariably leads to OA and,
ultimately, total hip arthroplasty (THA). The fact that most FAI diagnoses are made in patients under the age of
40, with many in their late teens and twenties, makes FAI all the more clinically challenging to treat. Due to the
limited life span of currently available hip implants, hip replacement in younger patients most often will require
at least one and possibly several revision surgeries later in life. Each revision surgery leaves the hip joint with
less native bone, resulting in a far less stable joint. FAI arises from abnormalities or defects in the bony
structure of the hip, typically taking the form of either asphericity of the femoral head or bony overgrowth of the
acetabulum itself. While a surgical intervention to remove the bony overgrowth addresses the painful
impingement between the two joint components (femoral head and acetabulum), it does not repair the chondral
defect caused by the bony malformation, which, over time, will progress and eventually lead to the need for
THA. Mosaicplasty or microfracture have been used in an effort to stimulate the re-growth of damaged
cartilage, but these procedures have not proven successful. Similarly, biological interventions utilizing stem
cells or platelet rich plasma preparations have not proven to have reliable clinical utility. It is clear that there is
an unmet need for an intervention that addresses the challenge of repairing damaged cartilage in patients with
FAI. In response to this need, Cytex has developed a therapeutic biphasic device consisting of a high-
performance 3D woven textile (cartilage phase) thermally bonded to an 3D printed scaffold (bone phase). This
implant immediately performs the functions of the replaced osteochondral tissues and provides a conducive
environment for native tissue integration and regeneration, demonstrated through multiple prior and ongoing in
vitro and in vivo studies. The goals of this application are as follows: (1) finalize all of the manufacturing
(cGMP) processes for the device, (2) file an investigational Device Exemption (IDE) with FDA to enable
a clinical study, and (3) conduct a single site feasibility (safety) study enrolling up to 15 patients
diagnosed with FAI. The patients to be enrolled will be qualified as surgical candidates for treatment of their
FAI and must meet a stringent set of inclusion/exclusion criteria in order to ensure participation in the study at
the lowest possible risk, while maximizing the possibility of a successful outcome. We have engaged several
partners in this application in order to maximize the possibility of a successful outcome. Our partners include
both regulatory and clinical development expertise in orthopaedic device trials and a Clinical Advisory Board of
experts in the diagnosis and management of hip preservation surgeries to treat FAI. We expect that positive
outcomes will move this technology closer to clinical practice by enabling a pivotal trial, but, also, positive
results will establish the role of our implants for other disease states requiring joint restoration surgery.

Public health relevance
Project Narrative The goal of this proposal is to conduct a First in Human pilot study in young and active patients who have been diagnosed with an arthritic condition known as femoroacetabular impingement (FAI). Our approach is to repair the arthritic tissue with a unique implant that is engineered to withstand joint loading while supporting the regeneration of diseased joint tissues. A successful clinical trial will pave the way for treating FAI and other debilitating joint diseases in young patients that currently have no good treatment options.